Aging, Burn Trauma, and Liver Damage

PROJECT SUMMARY
This proposal investigates why burns cause more severe liver damage in older individuals and devises an
innovative treatment strategy to counter this damage alongside a novel diagnostic approach for earlier
detection. This endeavor is crucial given the significantly higher mortality rate in older burn victims compared to
younger patients, necessitating age-specific interventions. Burn injuries have been found to affect multiple
organs, including the liver, which is highly susceptible to damage due to its unique structure and blood supply.
This project focuses on burn-induced liver damage, a well-documented yet untreatable issue particularly
prevalent in elderly populations. Our proposed studies investigate the role of MCJ (Methylation-controlled J
protein), a protein that negatively regulates mitochondrial metabolism in hepatocytes (liver cells) following burn
injuries in aged mice. We particularly focus on age-related factors such as increased production of pro-
inflammatory cytokines, which can modulate mitochondrial respiration and potentially cause liver injury. This
innovative approach will employ state-of-the-art methods for diagnosing mitochondrial respiratory dysfunction
and oxidative damage, as well as assessing liver function. Our preliminary data show increased MCJ
expression in the livers of aged mice postburn in settings of heightened age-related hepatic inflammation.
Furthermore, in vivo MCJ silencing in hepatocytes of aged mice reduced postburn mortality. From these
observations, we hypothesize that the inflammatory response after burn injury in aged subjects upregulates
MCJ expression in hepatocytes, leading to reduced mitochondrial respiration and subsequent liver damage
and dysfunction. We also predict that therapeutic silencing MCJ in hepatocytes can be a novel strategy to
attenuate the aberrant hepatic response to burn in older subjects. To test this hypothesis in Aim 1, we will
investigate how MCJ alters mitochondrial respiration in hepatocytes of aged mice postburn, potentially leading
to liver damage. In Aim 2, we will examine the role of pro-inflammatory cytokines, specifically tumor necrosis
factor-α (TNF-α) and interleukin-1beta (IL-1β), on postburn mitochondrial respiratory dysfunction and MCJ
upregulation. Lastly, in Aim 3, we will explore a novel liver-focused treatment using small interfering RNA
conjugated with N-acetylgalactosamine (GalNAC-siMCJ) for reducing postburn liver damage in aged mice by
silencing MCJ specifically in hepatocytes. In parallel, we aim to evaluate the potential of MCJ (DnajC15) mRNA
serum levels as a biomarker of liver damage in burn patients. This proposal holds transformative potential in
human health, particularly for aging burn victims. By innovating therapeutic approaches, we aim to significantly
reduce mortality rates and improve prognoses. Additionally, considering the heightened vulnerability of the
elderly population to liver diseases, our research could drastically affect a broad spectrum of liver pathologies.
Essentially, our work seeks to unravel the complex interplay between age, burns, and liver damage, laying a
solid foundation for pivotal future research and clinical applications.

Public health relevance
PROJECT NARRATIVE This proposal focuses on understanding why older people often suffer more severe liver damage from burns and finding new ways to treat and detect this damage early. Using state-of-the-art technology, we explore how burns may affect liver cell energy production, particularly in older individuals, leading to more damage and poor outcomes. Our project is primed to revolutionize the understanding and treatment of burn-related liver injuries, heralding the development of innovative medicines and diagnostic techniques that could notably augment survival rates and enhance overall health outcomes, especially in elderly individuals.